Prediction Model for Radiation Sensitivity in Children with Cancer

DESCRIPTION (provided by applicant): Survivors of childhood cancer have an increased risk of subsequent malignancy at another site. Previous studies in the Childhood Cancer Survivor Study (CCSS) have shown that the most frequent second malignant neoplasm is basal cell carcinoma (BCC), and that the most significant risk factor for BCC is exposure to therapeutic radiation. These data contrast with incident cases of BCC in the general population, for which the key risk factors are sun exposure and skin color. While it is clear that therapeutic radiation exposure increases risk of BCC in childhood cancer survivors, many are exposed to radiation and do not develop BCC. Thus, to address this inter- individual variation, given common exposures, we hypothesize that biomarkers of genetic susceptibility to BCC as a second malignancy will differ from those reported for incident cases. Furthermore, the occurrence of BCCs in childhood cancer survivors is potentially a marker of persons with increased radiation sensitivity. In this study, we will use a candidate gene approach in a case-control comparison to explore potential biomarkers that predict risk of BCC in childhood cancer survivors. We will validate positive observations from this investigation in two follow-up studies, which examine BCC in radiation technologists and bone marrow transplant survivors, to determine the generalizability of our observations. These validation studies are outside the work scope of this grant but will be key to the application of this approach to broader populations. We have selected a candidate gene approach for this study because the strong epidemiological data implicating ionizing radiation as the primary risk factor supports a hypothesis-driven approach to candidate gene selection. PUBLIC HEALTH RELEVANCE: Childhood cancer survivors have a high risk of developing basal cell carcinoma (BCC), a type of skin cancer, as a long-term side effect of radiation treatment. Some survivors may be genetically susceptible to developing BCC after receiving radiation treatment for their initial cancer. For this research project, we will develop a prediction model, using genetics and treatment history, to potentially help doctors tailor each patient's therapy to minimize radiation if the child has an innate susceptibility to radiation-induced BCC.

Public health relevance
Project Narrative Childhood cancer survivors have a high risk of developing basal cell carcinoma (BCC), a type of skin cancer, as a long-term side effect of radiation treatment. Some survivors may be genetically susceptible to developing BCC after receiving radiation treatment for their initial cancer. For this research project, we will develop a prediction model, using genetics and treatment history, to potentially help doctors tailor each patient's therapy to minimize radiation if the child has an innate susceptibility to radiation-induced BCC.